U S -MEXICO BORDER CONFERENCE ON WOMEN'S HEALTH ISSUES

"The U.S.-Mexico Border Binational Conference on Women's Health Issues: Meeting the Challenge of the Unique Needs of Women" will take place April 19, 20, 21, 1995 at the South Padre Island Convention Center, South Padre Island, Texas, U.S.A. The overall purpose of this conference is to provide a forum for participants interested in a variety of interrelated health issues affecting women along the U.S.-Mexico border to exchange information and explore opportunities for collaborative action. This forum is expected to improve the research, training and knowledge of women's health needs along the border and to identify strategies to meet these needs. The target audience includes approximately 400 health and social service providers, policy makers and others interested in women's health. A binational steering committee has been established to ensure relevancy of information presented and to ensure binational participation. Six content areas have been identified that need to be addressed in the proposed conference on women's health issues. Since both cancer and alcohol and other drug abuse are critical women's issues, they have been designated two tracks each. The other content areas include: reproductive health, STDs and HIV/AIDS; violence against women; mental health; and other topics including occupational health, osteoporosis, diabetes, self- care, barriers to health care access, and women in research. A total of fourteen workshops will be dedicated to cancer topics such as cancer data for the border; barriers to effective cancer screening; pesticides and cancer; breast and cervical cancer screening projects; environmental exposures and cancer; older women and prevention strategies; smoking trends and tobacco marketing targeting women and minorities; cancer support groups; reproductive cancers; breast cancer treatment options; HPV and cervical cancer; gender issues in screening and treatment; the role of nutrition in risk reduction; and cross-border utilization of cancer screening and treatment services.